Epigenetic biomarkers of Cervical HPV in women with oral and oropharyngeal HPV, precancer and cancer

Summary
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
23-038. Human Papillomavirus (HPV) is the most common sexually-transmitted infection worldwide, with nearly
all sexually active women and men infected during their lifetime. HPV infection is highly prevalent in Sub-Saharan
Africa (SSA), due to the lack of widespread HPV vaccination. Infection of hr-HPV strains, mainly HPV 16 and 18
strains, accounts for most cervical cancer (~99%) and oral and oropharyngeal cancer (85-96% of squamous cell
variety). HPV associated cancers are rapidly increasing in SSA due to lack of HPV vaccination and cervical
cancer screening programs like high income countries (HICs), such as U.S., as well as high prevalence of
HIV/AIDS. Infection with high-risk HPV (hr-HPV), mainly HPV 16 and 18, leads to oral potentially malignant
disorders (OPMD), the precancerous stage of oral and oropharyngeal cancers (OOPCs). Unlike cervical cancer
(CC) there are no well-developed, population-level screening programs for OOPC, even in high income countries
(HICs) such as the U.S. Epigenetic changes are a hallmark of cancer, and epigenetic biomarkers represent a
field with untapped potential for identifying women at risk of progression from exposure to carcinogens, such as
hrHPV infection, to pre-malignancy, and ultimately to invasive cancers. Now, there is no universal screening
strategy for women with oral or oropharyngeal cancer compared to cervical cancer. It is important to take
advantage of the ongoing R01 grant “Epigenetics of oral HPV and associated oral/oropharyngeal cancer in
people living with HIV in Nigeria” (EpOOCH) study to identify women that might also be at risk of having high-
risk HPV in the cervix at the same time (synchronous concordance) or in the nearest future (asynchronous
concordance). The aims of this project are: 1) To conduct cervical swab epigenetic profiling (at Northwestern) in
two groups of women: oral hrHPV and cervical HPV (n=30, Group 1) vs. oral hrHPV only (n=30, Group 2) to
identify cervical hrHPV-associated DNAm biomarkers also seen in oral and oropharyngeal sites. We will compare
epigenetic profile in both cervical swab (will be profiled by this supplement) and oral swab (have been obtained
in the parent R01 project R01CA27495201); and 2) To validate the hrHPV-associated biomarkers in cervix using
gene-specific DNAm PCR technology identified in Aim 1. This validation will be performed at University of Ibadan,
Nigeria. Our long-term goal for this mentored research is to develop biomarkers or tools that can screen or
identify women with hrHPV infections that could persist and develop into cervical cancer in future. This mentored
research Supplement will train the applicant, Sunday Oyerinde, MBBS, to gain new skills and expertise in study
design of molecular epidemiology projects, epigenomic processing and analysis, new assay development,
ethical and economically sound research techniques, and writing for peer review and grants.

Public health relevance
NARRATIVE Human Papillomavirus (HPV) is a prevalent sexually-transmitted infection worldwide and is linked to cervical, oral, and oropharyngeal cancer. This project aims to identify epigenetic biomarkers for women with high-risk oral HPV infection and concurrent high-risk HPV infections in the cervix. The mentored research will train Sunday Oyerinde, MBBS, in various skills including epigenetic testing, assay development, and grant and manuscript writing.